Mapping the Causal Genetic-Imaging-Clinical Pathway for Alzheimer's Disease

Project Summary/Abstract
Alzheimer's disease (AD) presents a massive public health burden, while resulting in signiﬁcant morbidity and
mortality. Recently, tremendous efforts have been taken to collect and analyze data from various pathophysio-
logical levels and in different experimental paradigms, but it has been difﬁcult to move from risk factors to causal
mechanisms, which may lead to new treatments for slowing or stopping AD. In response to NOT-MH-21-175 on
the use of human connectome data for secondary analysis, we will map the Causal Genetic-Imaging-Clinical
(CGIC) pathway for AD through jointly harmonizing and analyzing genetic, imaging, and clinical data
across multiple biomedical studies. To achieve this goal, we will develop Aim 1: a Robust Functional Connec-
tome Analysis (RFCA) framework to uncover the genetic architecture of human brain function by extracting robust
functional connectivity metrics at different levels; Aim 2: a CGIC framework to discover AD's causal pathways
starting from genes to AD progression-sensitive image features to AD cognitive measures and diagnosis; and
Aim 3: a CGIC prediction (CGIC-P) framework for AD risk prediction by using imaging genetic data integra-
tion. Furthermore, in Aim 4, we will verify the efﬁcacy of the newly developed statistical tools through extensive
Monte Carlo simulations and solve problems with clinical signiﬁcance by analyzing eight large-scale biomedi-
cal studies. These studies include the UK Biobank (UKB) study, the Adolescent Brain Cognitive Development
(ABCD) study, the Human Connectome Project (HCP), the IMAGEN study, the Alzheimer's Disease Neuroimag-
ing Initiative (ADNI) study, the A4 study, the Open Access Series of Imaging Studies (OASIS) and the Wisconsin
Registry for Alzheimer's Prevention (WRAP) study. The joint analysis of multi-type data, including imaging data,
genetics/genomics data, health records, and cognitive information, from these studies will provide insight into
the pathology of AD progression and healthy aging. The companion software (which will provide many needed
analytic tools for the analysis of imaging and genetic data) and the knowledge portal will be disseminated to
scientiﬁc community through our group BIG-S2's websites and NITRC. A variety of imaging genomic studies of
neuropsychiatric disorders, neurodegenerative diseases, and substance use disorders, as well as normal brain
development, will beneﬁt from our novel analytical methods and framework. In addition to AD, a better under-
standing of brain function and its genomic mechanisms, as well as the therapies used for AD, may inspire new
and urgently required approaches to prevention, diagnosis, and treatment of other brain disorders as well.

Public health relevance
Project Narrative This research targets at developing novel statistical tools for jointly analyzing the human brain functional activity and genetic information contained in biomedical datasets, and boosting the understanding of the human functional connectivity patterns, their genetic/genomic markers and their causal pathway for the Alzheimer’s disease across different scales. Our proposed methods will offer in-depth investigation of human functional connectivity variations that may contribute to clinical, behavioral and cognitive outcomes. We expect the accomplishments from this project to have significant impact in the understanding of the causal pathways of the Alzheimer’s disease.